MeCP2 reactivation from the inactive X chromosome as treatment for Rett syndrome

Project Summary
Rett syndrome (RTT) is a severe X-linked neurodevelopmental disorder that mainly manifests in girls without
effective treatment. RTT is caused by loss-of-function mutations of the Methyl CpG-binding Protein 2 gene
(MECP2) on the X chromosome. The majority of RTT patients are females heterozygous for MECP2 mutation,
in which random X chromosome inactivation (XCI) during development leaves ~50% of neurons without
functional MeCP2 protein, thereby creating cell-autonomous neuronal dysfunction. Corresponding mutations in
hemizygous males lead to severe neonatal encephalopathy and early death. Mice carrying null alleles of Mecp2
closely mimic symptoms seen in patients, including irregular breathing, stereotypical limb movements and
shortened lifespan, and are thus faithful models of RTT. Male Mecp2-null mice start exhibiting symptoms as
early as 30-60 days of age, with only half of the animals surviving beyond 75 days. Heterozygous females have
a near-normal lifespan with neurologic deficits that are delayed (~6 months) and highly variable in severity. A
major breakthrough in RTT research was the demonstration that RTT-like symptoms in adult mice can be
reversed by genetic or viral restoration of MeCP2 protein. Thus, reactivation of the silenced wild type (WT) allele
of MECP2 from the inactive X chromosome (Xi) presents an exciting therapeutic opportunity that attacks the root
cause of this disease by restoring MeCP2 function. Our preliminary data demonstrate that targeted
demethylation of the MECP2 promoter is sufficient to reactivate MECP2 from the Xi in human RTT ESCs and
neurons in vitro as well as in vivo in the RTT mouse brain. This was accomplished using a dCas9-Tet1 protein
targeted to the MECP2 locus via sgRNA, a DNA methylation editing tool pioneered by Dr. Shawn Liu. We
hypothesize that reactivation of MECP2 from the Xi will rescue RTT-associated phenotypes in mice. We have
developed two new transgenic mouse models (1,2) and two novel methods of delivery of epigenetic editors (3,4)
for MECP2 reactivation in vivo including: 1) Xi-linked Mecp2-NanoLuciferase-tdTomato dual reporter mice,
which enables high sensitivity detection and quantification of Mecp2 reactivation; 2) MeCP2-null heterozygous
female model of severe RTT with exclusive inactivation of the X-chromosome harboring the WT Mecp2 for
measuring reactivation-induced rescue which circumvents evaluating delayed and variable phenotypes in Mecp2
heterozygous with random XCI; 3) Cre recombinase-dependent dCas9-Tet1 transgenic line enables efficient
and tissue-specific DNA methylation editing in vivo; and 4) dCasMini-Tet1, in which the bulky dCas9 (4.1 kb) is
replaced with a compact dCasMini (1.6 kb) for delivery of a methylation editor via a single AAV9 vector. This
combination of transgenic models to measure reactivation efficacy (1) and rescue (2) with those that enable
efficient in vivo editing via genetic means (3) and single vector AAV9-mediated delivery (4) comprise a state-of-
the-art tool kit to evaluate the in vivo feasibility of a MECP2 reactivation strategy for treatment of RTT and other
X-linked disorders in females.

Public health relevance
Project Narrative The proposed research is relevant to public health because Rett syndrome (RTT) is an X-linked neurodevelopmental disorder caused by heterozygous loss-of-function mutation of the MECP2 gene in girls without effective treatment. We propose to apply our DNA methylation editing tools to reactivate the silent wild type allele of MECP2 gene from the inactive X chromosome. Our success in demonstrating MECP2 reactivation and functional rescue in RTT animal model will pave the way for future clinical trials of MECP2 methylation editing in girls with RTT.